Metabolic determinants of carbon dioxide tolerance in the pathogenic fungi, Cryptococcus neoformans

Project Summary/Abstract
Invasive fungal diseases account for 1.5 million deaths annually. Cryptococcus neoformans contributes to much
of this burden with a mortality rate that nears 70% and contributes to more than 180,000 deaths globally. The
high mortality rate is largely attributed to the lack of effective anti-cryptococcal therapies. Our long-term goal is
to understand the underlying mechanisms that drive Cryptococcus virulence and to exploit these mechanisms
for rational drug development. Virulence requires Cryptococcus to overcome many stressors imposed in the
human host. We have recently identified the ability to tolerate host carbon dioxide as a novel virulence trait. The
objective of this proposal is to specifically identify the mechanisms that allow for tolerance of host carbon dioxide
as a requirement for Cryptococcus virulence. A reverse genetic screen of kinases uncovered multiple effectors
of the protein kinase Tor as requirements for carbon dioxide tolerance. Tor is a known to regulate metabolic
processes across eukaryotes but is not well characterized in Cryptococcus. We performed metabolic profiling
under carbon dioxide stress and indeed uncovered a strong metabolic shift. This proposal sets out to define the
metabolic profile induced by carbon dioxide across diverse clinical and environmental isolates. We also identified
that general membrane stress and specific inhibition of sphingolipid biosynthesis potentiate carbon dioxide sen-
sitivity. Tor pathways are known to regulate acetyl-CoA metabolism and sphingolipid biosynthesis but are not
well characterized in Cryptococcus. Combining our investigation of these carbon dioxide response pathways
with virulence studies will help us uncover the underlying regulatory machinery and response kinetics required
for achieving carbon dioxide tolerance as a requirement for virulence. In this pursuit, we will achieve a more
direct understanding of the specific requirements for carbon dioxide tolerance. Our combination of genetics,
biochemical, and cellular approaches will guide us toward the underlying regulatory machinery and direct effec-
tors that dictate carbon dioxide tolerance as a requirement for virulence. The proposed experimental approaches
combined with professional development activities will provide a strong foundation for the applicant to launch an
independent scientific career.

Public health relevance
Project Narrative Cryptococcus neoformans contributes to 180,000 deaths annually with a mortality rate that nears 70%. This proposal investigates the underlying mechanisms that determine the role of carbon dioxide tolerance as a novel virulence trait. These findings will aid rational drug development strategies for a pathogen that currently lacks effective therapeutics.